Mouse Embryo Phenotyping Core

The goals and accomplishments during the past year are listed below. Meetings with various NIEHS investigators and staff for project set-up and coordination of project flow. Evaluation of embryos, placentae and implantation sites for gross lesions at select time points for abnormal phenotypes. Generation of gross findings report of embryo collections including photo documentation and genotyping results. In-utero and in-decidua embryo collection/dissection. Individual organ dissection from embryo (depending on age). Tail collection for embryo genotyping (tissue specific at different gestational ages). Age specific processing schedules and fixation methods of embryos and agar/paraffin embedding. Embryo sectioning at various planes, with step or serial sectioning, depending on project. Staining of slides with histological evaluation of embryos at select time points and postnatal animals as needed. Generation of histopathology report and histopathology slide review with investigators and staff.